Mitochondrial biogenesis, genetics and cell loss in mammalian aging

PROJECT SUMMARY/ABSTRACT
Mitochondrial biogenesis is a target of many aging interventions. While the induction of mitochondrial
biogenesis is generally thought to be beneficial, our data indicate that activating mitochondrial biogenesis at
old age drives the intracellular accumulation of mitochondrial DNA (mtDNA) deletion mutations and results in
an 18% loss of muscle fibers and a 1,200% increase in electron transport chain (ETC) deficient muscle fiber
segments. These effects were antagonistically pleiotropic; they were not observed in treated young rats. Based
on our data, up-regulation of mitochondrial biogenesis in aged humans may cause significant skeletal muscle
damage. These studies will clarify the role of mitochondrial biogenesis in mtDNA deletion mutation
accumulation and evaluate the old-age specific effects of compounds that stimulate mitochondrial biogenesis
in skeletal muscle. This project will: define the antagonistic pleiotropy of mitochondrial biogenesis in muscle
fiber loss; test the hypothesis that mtDNA deletion genome accumulation drives fiber loss; specify the order of
events and time required between mitochondrial biogenesis, mtDNA deletion mutation accumulation and cell
death; refine proposed mechanisms for deletion accumulation; determine if geroprotectors, which target
mitochondrial biogenesis, antagonistically induce mtDNA deletion mutation accumulation. By understanding
the mechanisms of inducing mitochondrial biogenesis at old ages, we will specify targets and treatment
strategies that mitigate the antagonistic effects. This K02 award, if funded, will protect the candidate's research
time from overextended clinical and administrative duties to allow further research development.

Public health relevance
RELEVANCE TO PUBLIC HEALTH A significant contributor to aging is the chronic loss of individual cells throughout the lifespan. With age, 46 percent of the muscle cells are lost, leading to frailty, a rapidly growing challenge to aging Americans. These studies will test mechanisms and explore interventions that affect the accumulation of mutations within the mitochondrial genome, muscle cell loss and muscle function.